Integrative Experimental and Multiscale High Resolution ModeIntegrative Experimental and Multiscale High Resolution Modling of Atrial Arrhythmias to Optimize Low Energy Anti-fibrillation Pacing (LEAP)

Project Summary for the supplement award PROJECT SUMMARY: Atrial fibrillation (AF) is the most common sustained cardiac arrhythmia: it contributes to 80,000 deaths annually and affects approximately 3.4 million Americans, with a projected increase to 10 million over the next 30 to 40 years. The primary electrical therapy for termination of AF, DC cardioversion, has significant side effects including electroporation and tissue damage, in addition to risks from sedation that can result in aspiration of stomach contents, pneumonia, and other problems. Radiofrequency ablation has a success rate of only up to 60% for paroxysmal AF, but less than 30% for persistent AF. Approaches to manage AF are not all successful and improvements are needed. In this supplement, we propose to further study and optimize our developed low-energy electrical therapy for AF suppression, low-energy antifibrillation pacing (LEAP). This consists of a train of 5 electrical pulses delivered at or near the dominant frequency of the arrhythmia from two field electrodes, rather than from a point source. We have shown that LEAP has a success rate of more than 94% and uses less than 10% the energy of cardioversion. LEAP suppresses AF by virtual electrodes created at heterogeneities within the tissue, which permits overdrive or underdrive pacing of AF. We hypothesize that synchronization is the mechanism by which AF is terminated via LEAP and thus, can be applied to any animal species and be optimized to be used in humans and eventually to be used as treatment requiring very small energies. In this supplement we are extending our implementation of LEAP to be delivered by a rotating field instead of a static field. This is a natural extension to our study, that grew out of discussions by the group team while performing and analyzing LEAP experiments. This is a perfect extension project for a graduate student to take and complete in the remaining time of the parent grant, as many of the required programs and experimental setups are already in place. The graduate student (Giraldo Pino) will extend the numerical simulations to study the effect of LEAP delivered by a rotating electric field, rather than a stationary one, he will also extend the LEAP experiments in porcine atria by implementing a rotating field in the experimental setup and also perform experiments. The hypothesis for this project, is that defibrillation has been shown to require lower energies when the field is applied along the axis of the cardiac fibers. Since the atrium has a complex anatomy with fibers rotating in various degrees through the right and left atria, it is expected that a rotating field would be able to excite intramural virtual electrodes with lower energies. This project adopts an integrative approach to optimize LEAP suing simultaneously simulations and experiments in porcine atria, therefore this project will train Mr. Pino in different areas and generate many new skills. Mr. Pino will iteratively perform numerical simulations and ex-vivo AF experiments in pig atria to test the hypothesis and use it to optimize electrode configurations for a rotating field to suppress AF using the lowest energies possible (below the pain threshold), Thereby paving the way for development of implantable devices using LEAP as another methods for managing AF in patients.

Public health relevance
PROJECT NARRATIVE: The method to be developed in this project will permit conversion of the heart rhythm disorder atrial fibrillation to a normal rhythm using low voltage rotating electric fields. Compared to the high voltage fields currently used, this new method will cause less damage to heart tissue, prolong the battery life of the device used to deliver the fields and cause less pain to the patient. Given that atrial fibrillation is the most common heart rhythm disorder in the United States and often is associated with debilitating symptoms, the development of a safer, more effective treatment for this disorder could benefit millions of Americans.